Motor and multisystem symptom clusters in children with Autism Spectrum Disorder (ASD): A SPARK dataset study

PROJECT SUMMARY
Motor impairments are pervasive in school-age children with Autism Spectrum Disorder (ASD); however, they
are often ignored and remain undiagnosed and untreated. Approximately 87% of the SPARK cohort of children
with Autism Spectrum Disorder (ASD), the largest ASD cohort in the US, is at-risk for a motor impairment/DCD
based on findings from the Developmental Coordination Disorder (DCD) Questionnaire (Bhat, 2020). Yet, motor
impairments are not part of the diagnostic criteria or specifiers for ASD per the Diagnostic and Statistical Manual
of Mental Disorders, 5th edition (DSM-V).
Although motor domain was added to the NIMH research domain criteria (RDoC) for mental disorders only last
year, motor issues have not been discussed as part of the RDoC for ASD. It is unclear if a unique pattern of
motor impairments and multisystem impairments (motor, social communication, and repetitive behavior) are
present in children with ASD. Do these patterns of impairment change across the ASD spectrum for certain sub-
phenotypes or are they generalized across sex, age, comorbid diagnoses, and levels of impairment?
In the proposed project, we will study the associations between motor impairment, autism severity, and
comorbidities in children with ASD. Specifically, we will determine the risk for motor impairment in children with
ASD and how that changes with increasing social communication impairment, repetitive behavior severity,
comorbidities, and levels of impairment using parent report measures: DCD-Q, Social Communication
Questionnaire (SCQ), and Repetitive Behavior Scale-Revised (RBS-R). Our analyses will also provide further
evidence for generalized but unique patterns of motor impairments in children with ASD and if present, the
presence of multisystem symptom clusters and sub-phenotypes of ASD.
We will also highlight the issue of differential access to various therapies (OT, PT, recreational) for children with
ASD and how those do not relate to a child’s risk for motor impairment, thus revealing under-diagnosis and
under-treatment for motor issues in ASD using PT and recreational therapies. As the COVID crisis evolves and
we wait for reliable treatments and vaccines, resuming pediatric face to face research will take a long time. Using
large databases such as the SPARK study dataset to answer critical research questions is therefore, timely and
essential.

Public health relevance
PROJECT NARRATIVE Motor impairments in children with Autism Spectrum Disorder (ASD) are often ignored and remain undiagnosed and untreated. In this project, we will determine how the risk for motor impairment changes with increasing social communication impairment, repetitive behavior severity, comorbidities, and levels of impairment using parent report measures obtained from the Simons Powering Autism Research for Knowledge (SPARK) cohort, the largest sample of children with ASD enrolled to-date (n=~24,000). We will also determine motor and multisystem clusters to reveal the generalized/unique as well as sub-phenotypic patterns of impairments in children with ASD.